ACTG 356--ZDV/3TC/NEVIRAPINE COMBINTION THERAPY IN HIV INFANTS AND CHILDREN

Four children from CHOP have been enrolled in this study of new combinations of antiretrovirals in infants and children. Nationally, 28 children out of a target accrual goal of 32 children have been enrolled. No preliminary data are yet available.